Developing a Hybrid Type 1 Effectiveness-Implementation Randomized Trial to Test a Table-Top Water Pitcher to Reduce Arsenic Exposure in Northern New England

PROJECT SUMMARY
Arsenic ranks first on the Agency for Toxic Substances and Disease Registry list of priority contaminants due to
its known toxicity and the high potential for human exposure. In addition to being an established carcinogen,
arsenic has been associated with a growing number of non-cancer outcomes, including cardiovascular
disease. Contaminated drinking water is the primary source of arsenic exposure worldwide. In the U.S.,
populations that depend on private wells for their drinking water are particularly susceptible to arsenic
exposure, as private well water is not regulated. Because arsenic is tasteless, odorless, and colorless, the only
way to determine if drinking water is contaminated with arsenic is to test a water sample through a certified
laboratory. However, because private well water is not regulated, this burden falls on the individual, and
consequently arsenic testing rates are typically low. Even after learning of elevated arsenic concentrations in
their drinking water, many people continue using the contaminated well water for cooking and drinking. This is
due in part to the cost and feasibility of implementing existing mitigation strategies, such as installing point-of-
entry reverse osmosis filtration systems. As a result, there has been growing interest in table-top water pitchers
as a possible low-cost and accessible option for reducing exposure to arsenic-contaminated drinking water.
Although a table-top pitcher has been identified that effectively reduces water arsenic concentrations in the
laboratory, its real-world effectiveness has not been tested. Additionally, barriers and facilitators to the
adoption, use, and sustainability of these pitchers have not been identified. There is therefore a need for a
hybrid type 1 randomized trial to test the effectiveness and explore the implementation of a table-top water
pitcher for reducing exposure to arsenic-contaminated drinking water. Through the proposed COBRE
Research Project, Dr. Howe (Research Project Leader) will gain expertise in implementation science methods
and conduct a feasibility study to generate preliminary data for an R01 application that supports the
development of this hybrid type 1 trial. The initial feasibility study will focus on New Hampshire residents, as
this is a state with a particularly high prevalence of private well users (50%) and elevated arsenic (25% of
wells). The subsequent hybrid type 1 trial will be scaled up to other populations across northern New England,
and future studies may further expand this to other IDeA states where arsenic exposure is also a major public
health threat. Findings from these studies may identify a low-cost and accessible intervention for reducing
exposure to a priority environmental toxicant and will inform strategies that improve the implementation of this
intervention.